ZERIT PLUS VIDEX VERSUS RETROVIR PLUS EPIVIR IN HIV PTS

The purpose of ths study is to evaluate the tolerance and comparative effects of ZERIT in combination with VIDEX and Crixivan versus Retrovir in combination with Epivir and Crixivan for a period of up to 48 weeks.